Determining the role of amygdalostriatal transition zone circuits in associative learning and motivated behaviors

PROJECT SUMMARY/ABSTRACT
The brain is able to form learned associations between stimuli and the rewards or punishments they predict,
which then guide appropriate behavioral responses to maximize survival. However, responses to
environmental stimuli are severely altered in neurological disorders such as anxiety, depression, and post-
traumatic stress disorder, leading to damaging behavioral outcomes. Understanding the neural circuits which
mediate learned associations and motivated behavior is therefore of crucial importance both from a basic
science and human health perspective. The amygdalostriatal transition zone (ASt) has circuit connectivity
which suggests a role in these processes, but the function of this region is almost completely unknown. The
central hypothesis of this proposal is that the ASt acts as a parallel circuit to the amygdala to mediate
associative learning and behavioral responses. In the mentored phase (K99) experiments, a combination of
optogenetics, in vivo electrophysiology and advanced computational analysis will be used to identify
subpopulations of neurons in the ASt that encode stimulus information and specific behaviors. The
independent phase (R00) experiments will determine the contribution of inputs from the thalamus, cortex and
lateral amygdala to ASt activity encoding cue information, and determine whether synapses from these
projections onto ASt neurons are strengthened in associative learning. Preliminary data for this study show that
1) genetically distinct populations of ASt neurons have opposing responses to cues predicting rewards or
punishments, and 2) optogenetic inhibition of one of these populations results in a striking reduction in
conditioned fear responses. This suggests that the ASt may indeed play a critical role in behavioral responses
traditionally attributed to the amygdala. A successful outcome of this proposal could therefore result in a major
conceptual revision of current models of the circuit mechanisms underlying associative learning. The study will
also provide new insight into the long-standing open question of how significant behavioral responses to
conditioned stimuli still persist even following bilateral loss-of-function manipulations targeting the amygdala.
This will not only increase our fundamental knowledge of the circuits underlying motivated behavior, but could
also identify ASt circuits as vital new targets of interest for neurological disorders where normal behavioral
responses to stimuli are disrupted. All proposed research will be conducted Dr. Fergil Mills in the lab of Dr. Kay
Tye at the Salk Institute for Biological Studies, which is fully equipped for the proposed experiments. The
proposal also includes a comprehensive training plan to facilitate Dr. Mills's career development, and will
prepare him to direct an innovative research program as an independent investigator studying neural circuit
mechanisms underlying normal and pathological behaviors.

Public health relevance
PROJECT NARRATIVE Normal responses to environmental stimuli are disrupted in many neuropsychiatric disorders, leading to damaging behavioral outcomes. This study will determine the role of the amygdalostriatal transition zone (ASt) - an almost completely unstudied structure - in mediating learned behavioral responses to stimuli that predict rewards or punishments. The proposed research project will increase our knowledge of the fundamental neural mechanisms underlying associative learning and motivated behaviors, and could identify ASt circuits as novel targets of interest for psychological disorders such as anxiety, depression, and post-traumatic stress disorder.